Parasite Genetics Core

Abstract
The aim of the Parasite Genetics Core (PGC) will be to enable the Southern and Central Africa ICEMR to
apply state-of-the-art next generation sequencing and bioinformatic tools to better understand malaria
epidemiology and the impact of control interventions in Zambia, Zimbabwe and the Democratic Republic of the
Congo (DRC). Specifically, the long term objectives and goals of the PGC are to provide; laboratory analyses
of parasites from ICEMR samples, bioinformatic processing of next-generation sequencing data for projects in
this previous aim, training for investigators in this and other ICEMRs, quality control of genetic data and
samples for analyses conducted at field sites. The PGC will provide a centralized laboratory for genetic
analysis of parasite samples from all three projects within the ICEMR. These laboratory analyses will focus
primarily on next generation sequencing techniques: (1) amplicon deep sequencing, (2) pooled amplicon deep
sequencing and (3) PoolSeq. The proposed laboratory work for the PGC includes activities in: Project A:
Malaria Control in Southern and Central Africa (Epidemiology), Project B: Intractable Malaria Vector
Populations and Residual Transmission in Southern and Central Africa (Transmission I), and Project C:
Achieving, Sustaining, and Documenting Malaria Elimination (Transmission II). Data analysis of next
generation sequencing is computationally intensive and rapidly developing. Thus, a portion of the core will be
dedicated to assisting investigators with these state-of-the art analyses. The facilities at the PGC will allow us
to host investigators from the Southern and Central Africa ICEMR, as well as collaborate with investigators
from other ICEMRs, in order for the techniques to be transferred to other institutions. This will allow us to
potentially foster cross ICEMR collaboration and to train non-US based scientists on state of the art population
genetics laboratory and analysis methods.